Impact of pathogenic missense mutations on the ARID domain of ARID1a

SUMMARY
The AT-rich interacting domain-containing protein 1a (ARID1a), also named BAF250a, p270, or hOSA1, is a vital
component of the Switch/Sucrose Non-Fermentable (SWI/SNF) chromatin remodeling complex. ARID1a, as part
of the SWI/SNF complex, is responsible for crucial nuclear activities, including regulating transcription, DNA
synthesis, DNA damage repair, and cell proliferation. Consequently, ARID1a is classified as a tumor suppressor
gene and it is frequently mutated in solid tumor malignancies cancers, amounting to ~6% of every cancer and
~45% of all ovarian cancers. Loss of function mutations in ARID1a due to frameshift, stop-gain, or missense
mutations leads to dysregulation of many gene pathways, including the prevention of tumor suppressor activities.
Although the loss of function is evident in stop-gain and frameshift mutations, the impact of pathogenic missense
mutations is subtler and more difficult to understand or predict. We hypothesize that pathogenic missense
mutations impact the protein stability, DNA binding affinity, and structural dynamics, perturbing its function.
Specifically, we seek to understand the effects of pathogenic missense mutations in the ARID domain of ARID1a,
which is responsible for its direct interaction with DNA. Therefore, the broad goal of this research program is to
understand the effects of pathogenic missense mutations in the ARID domain of ARID1a. The long-term
implications of this program are the development of a unique framework that will pave the way for directly probing
identified pathogenic missense mutations for future guided patient-specific screening therapeutic approaches.
Our proposed study integrates biophysical studies, computational approaches, and single-molecule
spectroscopy to characterize the stability, DNA binding, and structural dynamics of the ARID domain. Our studies
will give insights into the correlation between missense pathogenic mutations and the structure-dynamics-
function relationship. The PI and our research team are uniquely positioned to pursue the following specific aims:
(1) to determine the impact of pathogenic missense mutations on the stability of the ARID domain; (2) to
determine the impact of pathogenic missense mutations in the binding affinity of ARID domain to DNA; and (3)
to determine the changes in the structure and dynamics of ARID domain as perturbed by pathogenic missense
mutations. This interdisciplinary project will engage undergraduates in research to foster their interest and career
development in both physical sciences and cancer research. The expected outcome will be a structural model
of ARID1a’s ARID domain interaction with DNA, a library of pathogenic mutations ranked by the impact on
stability and affinity, a system to improve pathogenic predictors, and the foundation for developing novel
therapeutics and personalized medicine in the fight against cancer.

Public health relevance
NARRATIVE The AT-rich interacting domain-containing protein 1a (ARID1a) is classified as a tumor suppressor gene that is frequently mutated in solid tumor malignancies cancers. We seek to understand the impact of these cancer mutations of ARID1a and how they alter ARID1a protein stability, ARID1a binding to DNA, and how the protein folds. Understanding how these mutations impact the function of ARID1a are crucial for developing and implementing novel therapeutics and personalized medicine in the fight towards cancer.